Individual-specific engagement of cortical resources for standing balance control in aging and post stroke

Project Summary
Our long-term goal is to identify neural mechanisms of healthy and impaired balance to guide mechanistically-
based predictors, assessments, and interventions for addressing balance and gait impairments common in aging
and neurological disorders. It is well-known clinically that engagement of cortical resources in balance control
is an indicator of fall risk in older adults including stroke survivors, as inferred by the degradation of balance
and/or gait performance when a concurrent cognitive task shifts attention away from balance control scientific
barrier to improving prognostic tools, preventive strategies, and interventions for balance impairments is that we
lack an understanding of how and when cortical resources are engaged in balance control, particularly with
balance task difficulty. An innovation of our proposal is to identify direct, mechanistic measures of cortical
activity during reactive balance. We will combine MPI Ting’s expertise in the neuromechanics of reactive
balance control and MPI Borich’s expertise in human electrophysiology to identify relationships between brain
activity and motor function to improve stroke rehabilitation. Our objective is to identify cortical activity signatures
that distinguish individual-, task-, and group-level differences in the engagement of cortical resources for balance
control amongst young adults (Aim 1), older adults (Aim 2), and older adults with unilateral cortical lesions due
to stroke (Aim 3). We will measure electroencephalographic (EEG), electromyographic (EMG), and
biomechanical signals during reactive balance recovery to support-surface translations. We propose to use both
clinically feasible electrode-based analysis approaches, as well as mechanistically-important anatomically
informed functional analyses using high-density EEG in combination with structural and functional MRI scans.
We hypothesize that cortical activity signatures during balance control increase in an individual-, age-, and
disease-specific manner as balance task difficulty increases. Within groups, we predict individual variability in
cortical activity to be explained by balance challenge, i.e., balance task difficulty normalized to step threshold, a
measure of balance function. However, between groups, we predict cortical activity signatures and their relation
to balance challenge will differ. Aims are motivated by preliminary EEG data during reactive balance showing in
1) young adults, cortical activity is localized over leg sensorimotor cortical regions and increases with balance
task difficulty; 2) older adults, cortical activity is distributed over frontal cortical regions and is engaged at lower
balance task difficulty than in young adults; and 3) stroke survivors, slowed cortical activity is associated with
greater post-stroke gait impairment and distributed over frontal cortical regions in the contralesional hemisphere
If successful, we will identify neurophysiological indicators of balance health that will be broadly applicable across
the lifespan, and across neurological and orthopedic balance disorders to significantly advance the necessary
scientific framework to enable precision-medicine strategies for personalized, mechanistic assessments and
interventions to improve quality of life those with poor balance health.

Public health relevance
Project Narrative Although standing balance control is typically an automatic, involuntary motor function, increasing attention to balance is common in many older adults and is an important fall risk factor. A major clinical barrier is that this engagement of brain activity in gait and balance is inferred through indirect behavioral methods, limiting early detection and targeted intervention approaches. Our proposal provides a novel scientific framework for directly measuring brain activity during balance tasks to enable mechanistic, personalized, approaches to maintain and improve balance health in aging as well as the many neurological and musculoskeletal diseases affecting balance health.